Body Fat Compartments Imaging

, The four research projects in this P01 application on obesity and cancer will all use imaging-derived measures of body fat compartments as their exposures of interest. Imaging data at the two study sites [University of Hawaii (UH) and University of California (USC)] will be acquired by whole-body Dual X-ray Absorptiometry (DXA) and abdominal magnetic resonance imaging (MRI). Since data acquisition and analysis of imaging measures in a multi-center setting require specialized techniques and knowledge, we propose the creation of a dedicated

Public health relevance
RELEVANCE (See instructions): The Core's main role is to measure body fat amount and distribution in 2,000 Multiethnic Cohort participants (800 at the University of Southern California and 1,200 at the University of Hawaii) by conducting and analyzing whole-body Dual X-ray Absorptiometry (DXA) and abdominal magnetic resonance imaging (MRI) scans. The core will ensure that consistent, high-quality imaging data are collected across sites and over time in a cost-effective manner for use by all four research projects in this P01.